Inorganic Toxicology

Our mission has been to largely characterize toxic responses to carcinogenic inorganics to elucidate mechanisms. A major focus is on arsenic with a smaller cadmium (Cd) sub-projects. Inorganic carcinogens are major human hazards and characterizing their mechanisms is key to defining risk and designing methods of intervention. The development of rodent cancer models for arsenic is a recent advent and we have played a major role. We now generally use in vitro models with relevant cells. Cd is a well defined human and rodent carcinogen, so cell models were used to define mechanisms in recently established or suspected human targets. The further development of our mouse transplacental (TPL) carcinogenesis model has shown fetal inorganic arsenic exposure plus dimethylarsinic acid (DMA5+) causes oncogenic lesions at multiple sites, including known human targets like the kidney, and fortifies emerging human data concerning early life exposure and arsenic carcinogenesis. We now have also greatly lowered dose by using whole life (WL) exposure, which much more reasonably duplicates human environmental exposure. Tumor sites are unaltered but tumor incidence often increases, indicating fetal exposure dictates target tissues, pointing towards fetal stem cells (SCs) as target populations. We have treated mice in utero with methylarsonous acid (MMA3+), which is thought by many to be the ultimate carcinogenic metabolite of inorganic arsenic, and find it produces tumors in the offspring as adults in a fashion that is much similar to transplacental inorganic arsenic but requiring a much lower dose. Prenatal inorganic arsenic, which results or predisposes to mouse lung, skin and kidney tumors in adults, also causes an over-abundance cancer SCs (CSCs) in these same tumors. In in vitro work, we also find superior innate and acquired arsenic resistance in human prostate and rodent kidney SC lines, involving general and arsenic-specific adaptation genes. Malignant transformation of a heterogenous mature prostate line with arsenic causes a stunning CSC overproduction. A major question now is how arsenic targets SCs. Cells adapt to arsenic and arsenic-transformed skin keratinocytes adapt via diminished oxidative stress response. Once adapted, cells are cross-adapted to ultraviolet (UV) irradiation, but still show UV-induced oxidative DNA damage (ODD) at a level higher than control due to apoptotic by-pass, likely a basis of skin co-carcinogenesis with arsenic and UV. Arsenic biomethylation (BML) was thought to be adaptive but many target cells do not BML arsenic. The role of arsenic BML in ODD and transformation has been tested. When a BML-capable liver line and a BML-deficient prostate line were exposed to transforming arsenic levels, ODD occurred in BML-capable cells prior to transformation but BML-deficient cells showed no ODD despite exposure past transformation. Thus, arsenic BML is obligatory for ODD, and hastens acquired cancer phenotype, but cells can acquire a cancer phenotype without ODD indicating arsenic has multiple mechanisms. We can now test methylated arsenicals for ODD and linkage to transformation and look at epigenetic mechanisms of arsenic that may not involve ODD. We also find that arsenic consistently causes an overproduction of SCs, likely CSCs, during the malignant transformation process or after arsenic initiation of carcinogenesis in vivo. This is true with skin and prostate cells in vitro, and liver, skin and lung tumors in vivo. Arsenic-induced CSC overproduction is consistent compared to various organic carcinogens and to cadmium, so this may be a selective mechanism for the metalloid. The prostate is a potential human target of Cd. In contrast to arsenic, which selects for SC accumulation, Cd early on selectively kills SCs. Cd caused 95% cytolethality in our prostate SC line exposed to a non-toxic, but transforming, level for the heterogeneous parental mature line. Though depleted, remaining SCs rapidly undergo transformation, consistent with Cd as a single dose carcinogen. We will determine if Cd has transformed these SCs and observe the mature cell line for selection of hyper-resistant SCs. The pancreas is another potential human target of Cd. Human pancreatic epithelial cells are transformed by Cd, and then become highly enriched in CSCs. At early stages Cd also selectively kills pancreatic SCs but those that survive may be transformed. We are comparing Cd in other systems for this early bottleneck event and find this happens in the pancreatic cells as well. The pancreas is another possible human target of Cd carcinogenesis. NTP Laboratory projects are being formulated this year that involve the genotoxicity of stem cells from the circulatory system during inhalation as a possible mode of action for dissemination of cancer initiating cells, and genetic studies on a human population that had a high pulse of arsenic exposure during infancy and are showing increased tumor burden in their fifth decade. Other new NTP Laboratory studies are in in the formulation stage. We are also looking at strain related stem cell metabolism of carcinogens and how this might be related to eventual tumor burden.